Exploration into the Forgotten HIV Reservoir with Models of HIV/SIV Persistence in Mucosal Tissues

PROJECT SUMMARY/ABSTRACT
For many HIV infected people, lifelong combination antiretroviral therapy (cART) has converted the HIV
epidemic from death sentence into a manageable chronic disease. However, the HIV reservoir persists in all
treated individuals and viral rebound occurs upon cART interruption in the vast majority of patients. Given the
challenges related to lifelong cART treatment such as adherence, viral escape, toxicity, and costs, finding
novel ways to eradicate the virus and/or induce sustained virologic control in absence of cART is a very high
priority in the HIV field. Tissues are major sites for HIV latency and notable contributors to viral rebound after
cART interruption. Our preliminary data demonstrate that SIV infected mast cells (MC), a type of granulocyte
derived from myeloid progenitors may have an important, albeit understudied role in the persistence of HIV in
tissues. MC contribute to both the immune and neuroimmune systems and reside almost exclusively in
connective tissues and skin. Hence, until now the study of HIV infection of MC and their potential role in HIV
reservoir has been thwarted by logistical difficulties in both isolating these cells and identifying rare foci of
HIV/SIV infection in tissues especially during therapy. The technological advancements of our team led to the
identification of SIV infected MC at the time of rebound after antiretroviral treatment interruption in macaques.
This, in turn, led to ex vivo studies and the generation of preliminary data by a team of investigators with
expertise in both HIV and MC. Our preliminary data strongly support a role of tissue MC in HIV pathogenesis
and persistence. These tissue resident cells live much longer than lymphocytes and susceptible to infection at
least in a way that it is comparable to CD4+ T cells. Hence, we propose to use a variety of unique tools and
resources to explore the dynamics of HIV infection ex vivo and address the hypothesis that HIV infected MC
play an important role in the HIV tissue reservoir. Specifically, we will use tissues from non-human primate
studies (Aim 1) that will be collected via PET-CT-guided sampling from areas identified with active SIV
expression. We will characterize the frequency of infected CD4+ T cells and MCs in these areas during
different types of interventions. We will use ex vivo and in vitro infection (Aim 2) of human gut and skin derived
MC to understand the dynamics of HIV infection and persistence and the impact of different stimuli on HIV
replication in presence and absence of cART. Finally, we will use a humanized mouse model of MC (Aim 3) to
investigate questions similar to those addressed by Aim 2 either in vivo or ex vivo. In summary, we will
leverage a toolbox of different and complementary models and techniques to address the role of tissue MC in
contributing to HIV persistence and to determine how to manipulate and target this “forgotten” reservoir to
facilitate the development of novel, more comprehensive HIV cure strategies.